Collegiate recovery programming in the U.S.: An implementation science and mixed methods study

PROJECT SUMMARY/ABSTRACT
Substance use is a critical public health problem among college students in the US. Roughly 600,000 college
students report being in recovery from a substance use disorder (SUD). To support students seeking to maintain
or attempting to initiate SUD recovery, a growing number of US higher education institutions (at least 138) have
established collegiate recovery programs (CRPs). CRPs have expanded by 500% from 2013 to 2020, but there
are no current evidence-based standards to guide college staff, administrators, and communities on how to
establish a maximally beneficial CRP. This is at least partly because little empirical evidence exists on CRPs’
design, development, and implementation. To address this critical gap, I propose a mixed-methods study to
investigate CRP programs and create a pragmatic, context-sensitive, implementation toolkit for colleges across
the US. In Aim 1, I will conduct an ethnography at four well-established, geographically dispersed CRPs (Texas
Tech University, Augsburg University, Penn State University, and University of California at Santa Barbara) to
identify core characteristics and related barriers to and facilitators of CRP best practices. In Aim 2, I will conduct
a national survey among CRP program directors (n=50) and students (n=500) to characterize current CRP
programming and the evolution of CRPs over time. The survey results will be compared and contrasted with a
smaller national survey completed 7 years ago. In Aim 3, findings from the ethnography (Aim 1) and national
surveys (Aim 2) will be used to develop a CRP implementation toolkit. The toolkit will provide colleges with
appropriate insight on strategies to best disseminate and implement evidence-based interventions and practices
for students who are contemplating or in SUD recovery. Through the award period, I will build upon my clinical
training as a SUD counselor, doctoral training in experimental psychology, and experience conducting research
in SUD treatment to develop new knowledge and skills in ethnography, SUD recovery among emerging adults,
survey design, and implementation of CRP best practices. My proposed research plan integrates coursework,
formal training, practical experience, applied training, and mentorship from experts (Drs. Keith Humphreys, Mark
McGovern, Christine Timko, John Kelly, Alison Hamilton, and Kitty Harris) in addiction recovery, mutual-help
organizations, SUD treatment, quantitative and qualitative methods, and implementation science. This Mentored
Research Scientist Development Award (K01) will help me achieve my long-term career goal of being an
independent investigator with an established program of research focused on the development, testing, and
implementation of interventions for SUD treatment and recovery. In summary, the proposed research and
training plan will result in timely, innovative, and impactful findings on CRPs, ultimately leading to substantial
findings, high-quality publications, and improved health outcomes in the US.

Public health relevance
PROJECT NARRATIVE Collegiate recovery programs provide support for students in recovery from addiction as well as students seeking to recover. They’ve spread rapidly, but little is known about their availability, effectiveness, best practices, and utilization. In this project, I will describe collegiate recovery programs, identify their core elements, chart their national spread and draw conclusions about how they can be scaled up and evaluated.